WV DHHR Rapid Response Team Grant Funding

West Virginia Rapid Response Team
Project Summary
The primary objective of the West Virginia Rapid Response Team (WVRRT) is to provide
effective and efficient multi-agency responses to all-hazards as they relate to food and feed
emergencies which impact West Virginia. Secondary objectives include continuing to build on
existing relationships with other entities. Success in achieving WVRRT’s objectives will be
accomplished by strengthening our bonds with all involved with response to food or feed
emergencies, along with training, data sharing/analysis and transparency in communications
with our partners at the Federal, State, Local and Industry levels.
WVRRT project focuses on establishing food sample testing capacities, traceback needs, and
recall response. Two sampling exercises will be conducted yearly. Size and scope will vary, but
will include Public Health Sanitation field staff, lead food program staff, and Department of
Agriculture Food Laboratory personnel. The pathogens of concern for surveillance will be E. coli
O157:H7 and Cyclospora. The project will also include local health department personnel for
sample collection and for any environmental risk assessments that may be required. The project
will include creating just in time training modules for foodborne illness specific pathogens that
can be presented virtually and will focus on how to investigate, sample, and assess during a
foodborne illness outbreak based on WV DHHR Bureau for Public Health Foodborne Illness
Outbreak Investigation Manual.
Sampling projects were chosen due to increased prevalence of Cyclospora in West Virginia
during the spring and reoccurring multi-state outbreaks of E. coli O157:H7. The just in time
training modules have been included due to needs for more training that was identified during
the Cyclospora cluster identified in Spring of 2020.

Public health relevance
WV RRT Project Narrative Cyclospora cases in WV have increased annually and multi-state E. coli 015:H7 continue to reoccur. It is expected that the proposed surveillance sampling will provide a more in-depth scope of leafy greens distributed in WV. The objectives outlined in this grant match up with the RRT maintenance annual expected goals that include training, equipment, communication, and data sharing.